Protein & Small Molecule Chemistry Core

The Protein and Small Molecule Chemistry Core (Core C) will provide instrumentation, expertise and service related to the cloning, expression and purification of viral proteins and virus-like-particles (VLPs) as needed by each of the three major projects. In addition, the Core will provide chemical synthesis support for the small molecule inhibitor discovery efforts proposed in Projects 1 and 3. This core will provide the following specific functions: (1) cloning of wild-type and mutant genes encoding viral proteins into bacterial and insect expressions systems; (2) purification of viral proteins; (3) expression, purification and characterization of VLPs; (4) quantitation of interactions with antibodies, polysaccharides and small molecules; (5) synthesis of peptide arrays for diagnostics assays proposed in Project 1; (6) synthesis of small molecules to examine structure-activity relationships and increase potency of candidate molecules developed in Projects 1 and 3.

Public health relevance
The Protein and Small Molecule Chemistry Core will facilitate the discovery and development of molecules to be used as diagnostics or therapeutics for norovirus infections. The development of new diagnostics and therapeutics would have a positive impact on public health.